Association between cannabis and pain outcomes in a Tribally operated clinic

ABSTRACT
American Indians and Alaska Native (AIAN) people are disproportionately affected by chronic pain
conditions, including arthritis, diabetic neuropathy, and lower back pain. AIAN communities have also
experienced harm as a result of pain solutions offered by Western medicine, such as prescription opioids, which
have contributed to increased opioid misuse and mortality in AIAN people. Many AIAN people have turned to
Native medicine and other non-Western approaches to pain management. Thirty-four states have legalized
marijuana for medical use, while 12 states, and the District of Columbia, have legalized non-medical use, and
cannabidiol (CBD) derived from hemp is no longer a controlled substance. Therefore, cannabis products are
available to the majority of U.S. adults. 66% of adults think that cannabis provides pain relief, and 42% of
medicinal marijuana users report using it to relieve pain. While initial evidence indicates that cannabis
tetrahydrocannabinol [THC] has analgesic effects, the evidence for cannabis-associated reductions in pain
intensity and interference (i.e., the extent to which pain interferes with functioning) is limited. There is very limited
data about the effects of how a variety of cannabis products available on the legal market (e.g., different strains,
methods of delivery) and patterns of use impact pain outcomes and the comorbidities (e.g., mental health, sleep)
that are associated with pain. As a sovereign nation in Washington State, our Tribal partners developed the
Qwibil Clinic, which advises patients on the use of cannabis for the management of pain and other medical
problems. The Qwibil Clinic provides a unique opportunity to investigate the relationship between cannabis use,
pain, and pain-related factors in an AIAN owned and operated clinic. We propose a mixed-methods embedded
(QUANT+Qual) study to assess how cannabis impacts pain intensity and interference in a sample of n=350
patients seeking chronic pain treatment at the Qwibil Clinic. We will identify types and patterns of cannabis use
that are associated with pain outcomes over 12-months of care. We will also determine whether the effect of
cannabis on pain outcomes is mediated through known pain-related factors (i.e., negative affect, sleep problems,
self-efficacy) over time. To supplement our quantitative methods, we will use qualitative interviews to explore
how patients seeking care for pain experience cannabis and its impact on pain, including participants who differ
by sex, race (AIAN, Non-AIAN), and type of cannabis used. Finally, we will provide opportunities for AIAN
students enrolled in Washington State University medical, nursing, pharmacy, and prevention science graduate
programs and Northwest Indian College undergraduate programs to receive training and mentorship in cannabis
and pain research at the Qwibil Clinic, including training in qualitative and quantitative data collection and
analysis and dissemination of research results. Results will provide important information about the impact of
legal cannabis products on chronic pain in a mostly AIAN sample, providing important information to people with
pain, providers, and Tribal policymakers.